Elevating Community Voices by Developing a User-centered Approach to Enable Self-testing and Remote Data Collection among Under-represented Populations (Project Elevate)

PROJECT SUMMARY
The advent of remote technologies such as video conferencing and secure web-portals have revolutionized
approaches to health data collection and access to healthcare. For example, these technologies can be
deployed in fully remote and hybrid approaches for clinical trials which could help promoting more participation
among under-represented groups as well as by bridging geographic distance and reducing participant burden
(e.g., less travel time, more flexibility and confidentiality). Remote or online approaches can also increase
access to critical services (e.g., mental health counseling, sexually transmitted testing [STI] prevention) that
are scarce or geographically dispersed. However, these approaches have yet to be optimized for all possible
beneficiaries of technological advances in clinical trials and healthcare, especially targeting under-represented
populations that are disproportionately experiencing social and geographic isolation.
Groups like Asian American and Pacific Islander (AAPI – including Native Hawaiian), American Indian (AI)
and Hispanic/Latino populations are often under-represented in clinical trials, so much so that they often
occupy the racial/ethnic category of “other” in research studies. Notably, their under-representation not only
leads to this literal “othering,” but also prevents scientists from identifying their unique concerns which in turn
diminishing the relevance and effectiveness of technologies and distribution campaigns among them.
Sexual and gender minorities (SGM) such as gay, lesbian, bisexual, and transgender populations are also
often not strategically sampled for clinical trials, and SGM identities are often not even measured in clinical
trials. But many health concerns addressed in clinical trials are over-represented in SGM populations
compared to general populations (e.g., HIV, STIs, mental health concerns), thus, making many novel health
technologies (vaccines, antibiotics, hormonal therapies) disproportionately relevant to these populations. SGM
populations may experience social isolation at increased rates relative to the general population, which can be
further exacerbated by medical mistrust and stigmatizing experiences in healthcare and research contexts.
To address these concerns, the current proposal seeks to leverage the team’s existing community
connections in states across 4 different regions of the U.S. among the aforementioned groups to: (1) (a) co-
create and maintain 4 virtual and hybrid advisory groups to address health issues and (b) develop materials for
the conduct of remote advisory groups; (2) co-develop and administer a national needs assessment survey for
the referenced 4 groups (N = 800) addressing the use of home self-testing technology (up to 3 types) and
remote data collection for healthcare research and healthcare provision; and (3) pilot a community driven
approach to introducing home self-testing technology and remote data collection to potential participants from
these groups to assess feasibility and acceptability.

Public health relevance
PROJECT NARRATIVE The advent of remote technologies such as video conferencing and secure web-portals have revolutionized approaches to health data collection and access to healthcare, where these technologies can be deployed in fully remote and hybrid approaches for clinical trials which could help promoting more participation among under-represented groups as well as by bridging geographic distance and reducing participant burden (e.g., less travel time, more flexibility and confidentiality). However, these approaches have yet to be optimized for all possible beneficiaries of technological advances in clinical trials and healthcare, especially targeting under- represented populations that are disproportionately experiencing social and geographic isolation. To address these concerns, the current proposal seeks to leverage the team’s existing community connections in states across 4 different regions of the U.S. among the Asian American and Pacific Islander (including Native Hawaiian), American Indian, Hispanic/Latino, and sexual and gender minority populations to: (1) (a) co-create and maintain 4 virtual and hybrid advisory groups to address health issues and (b) develop materials for the conduct of remote advisory groups; (2) co-develop and administer a national needs assessment survey for the referenced 4 groups (N = 800) addressing the use of home self-testing technology (up to 3 types) and remote data collection for healthcare research and healthcare provision; and (3) pilot community driven approaches to introducing home self-testing technology and remote data collection to potential participants from these groups to assess feasibility and acceptability.